Deregulation of Sulfatide Synthesis in the Development and Progression of Pancreatic Cancer Precursor Lesions

Project Summary
The existence of asymptomatic precursor lesions that are known to predate invasive pancreatic ductal
adenocarcinoma (PDAC) by years provides a compelling “window of opportunity” for cancer interception efforts.
One such precursor is intraductal papillary mucinous neoplasm (IPMN). Using Matrix-Assisted Laser
Desorption/Ionization Mass Spectrometry (MALDI-MS) imaging of metabolites in tissue sections from resected
patient IPMN cases and from a KrasG12D/GnasR201C mouse model of IPMN, we have made a discovery in
identifying long chain hydroxylated sulfatide species that are selectively enriched in IPMN. Targeting of
sulfatide metabolism via small molecule inhibition of ceramide galactosyltransferase (UGT8), a key enzyme in
the synthesis of the sulfatide precursor galactosylceramide, suppressed sulfatide synthesis and induced
ceramide-mediated compensatory mitophagy, and subsequent apoptosis in Kras;Gnas IPMN cells and
suppressed tumor growth in an allograft mouse model of IPMN. The primary objectives of this proposal are to
1) define the biological role(s) of sulfatide in the development and progression of pancreatic cancer precursor
lesions, 2) test whether small molecule inhibition of sulfatide metabolism is a viable cancer interception strategy,
and 3) conduct a ‘proof-of-concept’ study that MALDI-MS imaging-based assessment of sulfatides can identify
positive margins and malignant nodules in challenging intraoperative frozen tissues from PDAC surgical
resections. In Aim 1A, we will use an unique cohort of patient-derived organoids (PDOs) established from
resected IPMN samples as well as murine-derived organoids (MDOs) and cell lines derived from Kras;Gnas
mice. Using CRISPR/Cas9 technology, we will establish UGT8-/-, galactose-3-O-sulfotransferase (Gal3St1-/-),
and double UGT8-/-/Gal3St1-/- knockouts to define the cell autonomous effects of sulfatide and sulfatide
precursors on mitochondria lipid composition, function, dynamics, and quality control. Findings will be further
integrated with transcriptomics, proteomics, and metabolomics data. In Aim 1B, we will investigate the role(s)
of sulfatide in promoting the initiation and progression of pancreatic precursor lesions and evaluate its impact on
the nascent tumor microenvironment and immunophenotype using orthotopic mouse models of parental and
isogenic (e.g. UGT8 KO) model systems established in Aim 1A. To assess for clinical potential, in Aim 2, we will
test whether targeting of sulfatide metabolism using an selective small molecule inhibitor of UGT8 attenuates
the development of precursor lesions and invasive carcinoma in Kras;Gnas mice. Given the observed specificity
of sulfatide to pancreatic precursor lesions and carcinomas, in Aim 3, we will collect intraoperative surgical
margins and suspicious metastatic nodules from patients undergoing PDAC surgical resections at MD Anderson
Cancer Center, and we will test the extent to which MALDI-MS imaging of sulfatides can identify involvement by
cancer cells. Potential findings from our studies may lead to cancer interception strategies and imaging-based
diagnostic applications for PDAC.

Public health relevance
Project Narrative We have made novel and potentially far-reaching discovery in identifying a highly specific lipid signature consisting of hydroxylated sulfatide that is associated with the development and progression of pancreatic cancer precursor lesions and that underlies an actionable metabolic vulnerability with therapeutic potential. The primary objectives of this proposal are 1) to interrogate and define the biological role(s) of sulfatide in promoting tumorigenesis and in reshaping the tumor-immune microenvironment, 2) to test whether small molecule inhibition of sulfatide metabolism is a viable cancer interception strategy, and 3) to investigate the potential of sulfatide imaging for margin assessment of pancreatic tissue specimens from surgical resections. Potential findings from the proposed studies have may likely lead to novel preventative strategies as well as imaging-based diagnostic applications.